Core A: Administrative Core

Abstract The Administrative Core (Core A) will provide all administrative and fiscal support for the Program. Administrative support will include arranging meetings, conference calls, handling all PPG-related correspondence, preparing documents, and submitting collaborative manuscripts. Fiscal support will include maintaining and reconciling accounts, preparing budgets, and arranging subcontracts. The Administrative Core will also assist with noncompeting and competing renewals, organize monthly PPG meetings and annual retreats, and importantly, maintain a secure file server for data sharing for the project leaders to easily access and share data among the 3 institutional sites, and provide assistance with Webex conferencing.

Public health relevance
Narrative The purpose of Core A (Administrative) is to provide administrative, fiscal, and information technology (IT), support to all projects within the PPG.